Interferon-modulated vaccines against HIV

Project Summary
The main goal of the parent grant is to develop interferon-modulated vaccines against HIV. The
proposed research will follow up on the same unifying concept of our parent DP2 grant, but in
addition, it will consider the effect of boosting with a heterologous vaccine. Bakare has observed
that boosting with a heterologous vaccine regimen enhances the efficacy of vaccines (manuscript
in preparation). The preliminary data shown below is with SARS-CoV-2 vaccines, but it
demonstrates a potentially novel and universal strategy to improve viral vaccines against HIV and
other infectious agents that affect PWID. Improving vaccine efficacy is also critical to improve the
lives of PWID.

Public health relevance
Project Narrative: People with substance use disorders (SUD) are highly susceptible to HIV infection. In this grant we will develop highly immunogenic HIV vaccines for people with SUD.